T32 Training Program in Pediatric Immuno-Oncology and Immunotherapy

PROJECT SUMMARY/ABSTRACT
The Pediatric Immuno-oncology and Immunotherapy T32 training program is designed to train postdoctoral
fellows with the interdisciplinary skills and knowledge that are necessary to become highly productive scientists
in this field. Immunotherapy for pediatric cancer patients has the potential to revolutionize how we take care of
pediatric cancer patients and holds the promise to provide cures for currently ‘incurable pediatric cancers’. The
high specificity of such immunotherapies should reduce toxicity and long-term adverse effects. However, the
success of this therapeutic approach will depend on our ability to attract promising young investigators into the
field. Despite obvious differences between adult and pediatric cancer, there is currently no pediatric immuno-
oncology T32 training program funded by the NIH, and our proposed training program fills this gap. There is an
urgent need for discovery-based research, in particular to define the immune landscape of pediatric cancer, and
to strengthen research focused on translating immunotherapeutic approaches into early phase clinical studies.
This can only be accomplished by providing systematic, rigorous training in pediatric immuno-oncology and
immunotherapy, and this T32 training program meets this need. We are requesting three postdoctoral positions
to support interdisciplinary training in immuno-oncology and immunotherapy within our institution. Pediatric
immuno-oncology and immunotherapy is a very broad topic, and the training has been designed to expose
trainees to the most important topics, while also providing tailored preparation for a career in pediatric immuno-
oncology-related research. Training will be a combination of basic science concepts and techniques, translational
research, animal studies, and professional development, including scientific writing and grant preparation.
Trainees will present their work annually as part of the T32 program’s Training Day, which will be held in
conjunction with an on-site visit from our External Advisory Committee (EAC). It will comprise research
presentations by trainees to program faculty and the EAC, a featured lecture from an EAC member, and
evaluation of the program by the EAC. St. Jude Children’s Research Hospital provides an ideal environment for
the proposed T32, with cutting edge technologies, numerous core facilities including an onsite Good
Manufacturing Practice facility, and dedicated faculty who are committed to training young scientists. Moreover,
it is the home of the only NCI comprehensive cancer center that is solely focused on pediatric cancer. Importantly,
it is committed to developing the next generation of pediatric immunotherapies through its strategic plan and
multi-investigator initiatives. St. Jude provides a rich intellectual environment with formal and informal interaction
between laboratories and research programs in multiple institutional lecture and seminar series, providing ample
opportunities to trainees for additional research training and career development. In summary, we are committed
to training the next generation of scientists in the field of pediatric immuno-oncology and immunotherapy, which
holds the promise to cure pediatric cancers with minimal treatment-related harm.

Public health relevance
NARRATIVE Immunotherapy is a promising treatment for pediatric cancer that can improve outcomes while minimizing toxicity and the long-term adverse effects associated with other types of therapy. The success of this treatment requires more discovery-based researchers who aim to improve understanding of how pediatric cancer cells interact with the immune system, and translational researchers to refine immunotherapeutic approaches for use in early phase clinical studies. The Pediatric Immuno-Oncology and Immunotherapy training program is designed to provide integrated training in advanced research approaches in a clinical context to foster the development of the next generation of independent scientists leading the field.